Ti-catalyzed cascading hydroaminoalkylation as a route to complex functionalized amines

Project Summary/Abstract
Central to the development of medicine is organic chemistry and catalysis as it has permitted the
discovery of new reactions and methods for the synthesis of key pharmaceutical components that will
play a critical role in continuing the advancement of modern medicine. With the high presence of
nitrogen atoms in drug candidates due to their high biological activity, it is crucial to develop new and
innovative methods to synthesize and functionalize nitrogen-containing molecules. Recently, reactive
titanium intermediates were used to explore second insertions of unsaturated species yielding useful
nitrogen heterocycles. This proposal will focus on developing an efficient and one-step atom-
economical Ti-catalyzed multicomponent, cascading hydroaminoalkylation reaction to produce β-
cycloalkyl amines from dienes and amine/aniline substrates. This methodology has potential to be a
valuable synthetic tool because β-cycloalkyl amines products are scaffolds present in pharmaceutical
compounds such as cyclopentamine and propylhexedrine and in M3 muscarinic antagonist.
Additionally, this method will provide a fundamental understanding of this new reaction class that can
be extended into other cascading reactions to rapidly build molecule complexity.

Public health relevance
Project Narrative Innovative method development to synthesize nitrogen-containing molecules are of importance due to the high presence of nitrogen in pharmaceutical drug candidates. Methods to use reactive early transition metal metallazirdine offers a transformative approach in the preparation of selectively substituted amines and N- heterocycles due to its high atom economy and tunable catalyst and reaction conditions. New methodology and catalysis reactions control selectivity, achieve high reactivity, and expand on the amine substrate scope that can be further functionalized towards the synthesis of pharmaceutical drug candidates.